Gravida traumatic brain injury (TBI) impacts neurodevelopment of the offspring

PROJECT SUMMARY
Intimate partner violence (IPV) increases the risk of traumatic brain injury (TBI), because the physical assaults
target the head, neck, and face. Women, more than men, across socioeconomic, racial, educational, regional,
and other demographic variables are in harm’s way throughout their life and particularly during pregnancy. When
one partner is pregnant, the frequency and intensity of physical assaults increase and remain focused on the
head, neck, and face. Whether from IPV, falls, or automobile accidents, the consequences of a TBI during
pregnancy (gravida TBI; gTBI) on offspring neuro-development are unknown. Isolated TBI elevates stress and
inflammation, which are known to divert fetal neuro-development with gestational exposure. The proposal goal
is to provide proof-of-concept that gTBI can disturb neurodevelopment, thereby establishing gTBI as an
environmental risk factor for developmental disorders. These studies cannot be performed in people or be
derived from existing databases, thereby warranting laboratory studies. Preliminary data from this research team
showed live births, low male weaning weight, distorted cortical circuity, reduced anxiety and depression, and a
muted immune response principally in male gTBI offspring. These results encourage further investigation of TBI
timing with respect to pregnancy, broader assessment of neuropsychiatric outcomes, enhanced neural circuit
analyses, and molecular investigations of cell and synaptic change. The extent of neurodevelopment disruption
is compared to a standard model of maternal immune activation (MIA) and respective controls. The central
hypothesis of this proposal is that TBI during pregnancy leads to disrupted neurodevelopmental trajectory in the
offspring that includes altered neurobehavioral performance, neurocircuit organization, and cell type-specific
molecular disturbances. To test this hypothesis, a diffuse TBI will be delivered to timed- pregnant mice at 5 and
12 days post-coitum and then follow male and female offspring in terms of: [Aim 1] birth outcomes, offspring
physiology, neurobehavioral phenotype; [Aim 2] neurocircuitry phenotype, and [Aim 3] synaptic protein
expression and cortical cell type-specific gene expression (transcriptomics). Aim 1 will evaluate early post-natal
behaviors; cognition, anxiety, depressive-like, and sensorimotor gating in young adult; and social behaviors in
adult offspring. In Aim 2, cortical and hippocampal synaptic physiology and cortical connectivity will be evaluated
by electrophysiology and laser scanning photostimulation, and aligned with quantitative neuronal morphology.
In Aim 3, western blot quantification of synaptic proteins and cell type-specific transcriptomics inform circuit
development and molecular trajectories. Impact: Successful completion of the proposed studies will provide the
first proof-of-concept that consequences of TBI during pregnancy, often resulting from IPV, can distort
developing brain circuity and determine a neurodevelopmental disorder behavioral phenotype.

Public health relevance
PROJECT NARRATIVE Intimate partner violence (IPV) includes assault to the head, neck, and face, with approximately 90% of survivors reporting symptoms concordant with persistent post-concussion symptoms, wherein pregnancy is associated with increased intensity and frequency of physical assault. Like stress, drugs, and inflammation, traumatic brain injury (TBI) during pregnancy, from IPV, falls, motor vehicle accidents, can increase the environmental risk for neurodevelopmental disorders in the children. The proposal extends strong proof-of-principle results to explore the outcomes of gravida TBI – TBI during pregnancy – in mice on the neurobehavioral, neurocircuitry, and molecular phenotypes of offspring to better inform science, education, and policy making.